3D Methodology for Interpreting Disease-Associated Genomic Variation in RAG2

PROJECT SUMMARY
The current proposal seeks to advance mechanisms of interpretation of genomic variation found in RAG2. We
leverage advanced computational techniques with existing and new experimental data, to develop a novel
approach for characterizing and interpreting inter-individual genetic variation, and mutations observed in patients
with immunodeficiency syndromes. Our central hypothesis is that structural calculations predict functional
changes for RAG2 mutations via capture of specific biochemical and molecular mechanic features. Our approach
investigates RAG2 mutations in a domain-specific manner, where each Aim investigates one of the two RAG2
structured domains: 1) we interrogate the effects of β-domain mutations on the RAG heterotetramer complex
across its enzymatic cycle; 2) we computationally and functionally characterize how mutations in the plant
homeodomain alter stability and chromatin binding capacity. Thus, between the two domains, we will investigate
alteration of the RAG enzyme and its ability to be regulated by differentially targeting to the correct places in the
genome, via its histone reading function. Our Aims are independent (using different approaches for different
domains), yet synergistic due to each providing new information about RAG2 mutations observed in
immunodeficiency patients. Both domains will be characterized in structure-dynamics-function paradigm, to
elucidate details for each mutation in high-resolution, and to identify subgroups of mutations that have similar
effects on RAG function. The subgroups we anticipate identifying will serve for follow-up studies into cellular
effects and how to potentially address each type of dysfunction. When completed, the proposed studies will
generate new data with clear biomedical relevance for diagnosis of immunodeficiency syndromes and enabling
future research in how to differently address each group of mutations that modulate specific dimensions of RAG
complex function. At a higher level, our proposal addresses a broad unmet need in genomics for new
computational approaches to mechanistically interpret the wide landscape of human variation. We anticipate that
the approach used here, will be generalizable to other proteins for how the computational tools can be applied
in a robust manner to determine the underlying protein structure-function relationship for interpreting the
structural biology of genetic disease pathogenesis. The data generated in this pilot award will thereby seed future
applications by the current scientific and multi-disciplinary team, to further expand our understanding of RAG
genetic variation and its effects on the immune system.

Public health relevance
PROJECT NARRATIVE The current proposal will develop the means to bring powerful computational tools from basic sciences to bear for interpreting the effects of RAG2 genetic mutations identified through genomic sequencing. As genetic data is increasingly available, the need for better tools to interpret their effect has an increasing potential to improve the health of individuals through Precision Medicine. Our study is an innovative approach for its novel combination of computational scores, parameterized by and validated using experimental data, and biomedically relevant for powering next-generation interpretation of genomic variation leading to immunodeficiency syndromes.